Disconnecting CR2/CD21 from Its C3d Ligand to Ameliorate Lupus

DESCRIPTION (provided by applicant): Complement receptor type 2 (CR2/CD21) and its primary C3 activation fragment-derived ligand designated C3d play a central role in the development of high affinity antibodies to foreign antigens. The primary B cell receptors for antigen-bound C3 fragments in mice are CR2 and complement receptor type 1 (CR1/CD35). As opposed to humans, where unique genes encode these proteins, mouse CR2 and CR1 are derived through alternative splicing from a common gene designated Cr2. The larger CR1 protein is the primary receptor for the C3b form of C3 as well as antigen-bound C4b, while the smaller CR2 protein only binds C3d with a high affinity. High affinity autoantibodies and B lymphocytes play central roles in the immunopathogenesis of human systemic lupus erythematosus (SLE). In principle, given our current understanding of the immune basis for the development of SLE through subversion of normal tolerance checkpoints and development of autoreactive responses, one might expect a similar enhancing role as found with foreign antigens to be played by CR2 interactions with C3d-bound self-antigens in SLE. However, prior studies using gene-targeted Cr2-/- mice, which lack both CR2 and CR1, in murine models of SLE have not supported this presumption and have suggested that CR2, in addition to CR1, expression is necessary to maintain tolerance to lupus-related self- antigens. It is straightforward to understand how CR1 could play this role as a high affinity receptor for C4b, which is itself necessary to maintain tolerance to self-antigen in mice and humans. However, no similar experimentally supported role exists for CR2, and thus how expression of this particular receptor could be needed to protect from autoimmune disease development in SLE remains enigmatic. To address this question, we have overcome the technical challenges that exist in the murine CR2/CR1 receptor system by developing new highly specific mouse anti-mouse monoclonal antibodies (mAbs). The first is a non-B cell depleting mAb that recognizes and blocks only CR2/CD21 function without directly affecting CR1 interactions with C4b or C3b. The second mAb recognizes the C3d fragment at its receptor binding site and blocks its interaction with CR2 without affecting C3b or C4b interactions with CR1. With these newly developed tools and pursuing the following specific aims, we will for the first time be able to test the hypothesis that disruption of the critical C3d- CR2 ligand-receptor binding step alone will ameliorate, rather than enhance, autoimmunity and clinical disease in SLE: Specific Aim #1. Evaluate the effects of specific monoclonal antibody-mediated blockade of CR2/CD21 function on the evolution of autoimmunity and clinical outcomes in the MRL/lpr model of human lupus; and Specific Aim #2. Using a novel C3d-specific monoclonal antibody to interrupt the interaction by C3d-bearing autoantigen complexes with CR2/CD21, characterize the ameliorative effects of this strategy on the evolution of autoimmunity and clinical outcomes in the MRL/lpr model.

Public health relevance
The proposed research is relevant to public health because it focuses on evaluating a pathophysiologically important mechanism in the autoimmune disease systemic lupus erythematosus. Using tools we have created specifically for this purpose, the role in this disorder of an important receptor-ligand system will be defined. The proposed research addresses questions directly bearing on the programmatic goals of NIAID focused on supporting novel research into the causes, treatment and prevention of autoimmune diseases.